Facioscapulohumeral dystrophy clinical trial foundations

Summary/Abstract
Project 2: Facioscapulohumeral Clinical Trial Foundations
Project 2 will establish facioscapulohumeral dystrophy (FSHD) clinical trial foundations. The success in
identifying the molecular and genetic mechanisms of FSHD provides a strong basis for drug development and
therapeutic clinical trials. A major barrier to drug development is lack of validated biomarkers for early phase
and proof of concept gene targeted therapies. In addition, the lack of understanding progression over time
limits trial design and clinical care. In our prior Wellstone we showed quantitative fat fraction on MRI can
demonstrate progression over 1-2 years; with certain MRI features (STIR+, and intermediate fatty involvement
at baseline) predicting faster progression rates. The same MRI features also correlated with a basket of FSHD
related genes in needle muscle biopsies – including genes related to DUX4 expression, inflammation, and
extracellular matrix. Here we plan to extend and expand our foundations for clinical trial preparedness. The
broad and long-term goals of this study are to further refine our understanding of MRI as a biomarker by
applying artificial intelligence driven automated segmentation and analyses to existing and new long-term
follow up data, apply our MRI and molecular biomarkers to a safety and tolerability study of clenbuterol, a drug
we identified as inhibiting DUX4 in patient derived cell assays, and using these tools to validate and phenotype
a new large mammal model of FSHD type1. This will be accomplished by (Aim 1) extension of the longitudinal
clinical study cohorts of FSHD to additional long-term functional and MRI assessments with improved MRI
analytic techniques; (Aim 2) perform a prospective 6-month open label multiple ascending dose safety and
tolerability study of clenbuterol in FSHD with secondary outcome measures that include functional studies, MRI
characteristics, muscle histology, and the muscle molecular signature; and (Aim 3) validating a porcine model
of FSHD1 and generating bioresources to support the development of pigs as preclinical models for FSHD.
Together, these aims will (1) further validate, refine, and extend clinical, MRI, and molecular measurements of
disease activity and progression in FSHD muscles to allow for a better understanding of FSHD progression
and the size of change that will be clinically meaningful and ; (2) determine whether clenbuterol is safe and
tolerated, and which dose may show preliminary signs of efficacy to support a future phase II clinical trial; and
(3) validate a new porcine model of FSHD1 using these functional, MRI, and molecular measurements. The
significance of this study is that it will strengthen and extend the foundations for clinical trial design and help
hasten therapeutic development for FSHD.